CONTRAST AGENT DEVELOPMENT &RELAXOMETRY

New dendrimer-based agents for blood pool contrast and targeting to cancer cells have been developed and tested in vitro and in vivo. Continuing studies of gel-based agents have revealed complex dynamic and morphological changes. A comprehensive theory of their effects on water relaxation has been developed and is under test.